Transcriptional Co-Regulators in Epidermis

PROJECT SUMMARY/ABSTRACT
Although the epidermis is composed of morphologically distinct layers, single-cell RNA-seq experiments indicate
that epidermal differentiation does not progress in discrete steps at a transcript level but is instead continuous
and gradual. Consistent with this notion, we identified a large population of basal-to-spinous transition cells that
reside in the basal and first spinous cell layers. These transition cells are found throughout the lifetime of the
mouse and in the adult human palmoplantar and non-palmoplantar epidermis. Our hypothesis is that the
presence of these transition cells does not reflect an ineffectiveness in switching from basal to spinous gene-
regulatory programs. On the contrary, we propose that basal-to-spinous cells are actively maintained through a
specific gene-regulatory program. We will use single-cell and spatial transcriptomics approaches to study the
cellular composition, gene expression, and predicted function and cell-cell signaling in the P0 epidermis from
mice knocked out for transcription factors whose expression peaks in transition cells. We will use single-nuclear
ATAC-seq with single-nuclear RNA-seq to map changes in open chromatin across cell states, including in basal-
to-spinous transition states. We will also define transcription factor binding and histone modifications in sorted
epidermal cells from distinct differentiation stages. We will then use computational modeling to define the
underlying gene regulatory networks and to inform further functional testing on the role of signaling pathways
and transcription factors in maintaining the basal-to-spinous transition cell state. This work is significant and
innovative because it addresses a recently recognized cell state in epidermal differentiation, basal-to-spinous
transition cells, which have not been investigated.

Public health relevance
PROJECT NARRATIVE Defective epidermal differentiation and barrier formation contributes to a number of skin diseases including ichthyosis, palmoplantar keratoderma, atopic dermatitis, psoriasis and skin cancer. Understanding the control of epidermal differentiation will ultimately contribute to our understanding of these skin diseases.